Multiplexed Mapping of Immune Infiltrates

DESCRIPTION (provided by applicant): New technologies are needed to enable the molecular characterization of the complex relationship between the immune system and cancer. This proposal aims to apply a novel approach to high-dimensional analysis of cancer samples, in order to determine if it can help to elucidate the interactions between the immune system and cancers, and ultimately to correlate these effects with outcome.

Public health relevance
PUBLIC HEALTH RELEVANCE: The interaction of the immune system and cancer is important to outcome but is poorly understood. We are developing a more powerful way to analyze this complex interaction. If successful, this project may enable improvements in the molecular analysis and treatment of cancer.